Molecular function of Myosin-l

SUMMARY
The goal of the parent R37 project is to determine the molecular mechanisms of the myosin-I
family of motors. Myosin-Is comprise the largest unconventional myosin family found in humans,
and its large size and expression profile distinguish it as one of the most diverse. Myosin-Is
physically link cell membranes to the underlying actin cytoskeleton where they play essential roles
in powering membrane dynamics, membrane trafficking, and mechanical signal-transduction.
Discoveries made during the tenure of this award include revealing (a) synergies between myosin-
I and Arp2/3 mediated actin polymerization, and (b) the mechanisms by which non-muscle
tropomyosins regulate myosin-I activity and subcellular localization. Exciting new experiments
will provide the mechanistic details necessary to understand how these proteins use the
mechanochemical cycle of myosin to bring about changes in membrane structure and dynamics.
To accelerate progress of our Aims, we require the ability to quantify the binding, kinetics, and
distribution of fluorescently labeled proteins at the single-molecule level via TIRF microscopy.
Our current equipment is built on a > 20-year-old microscope that does not have the ability to
acquire data with the positional and temporal resolution or wavelengths necessary to address our
questions. Additionally, the software running the system is no longer supported by the
manufacturer, which will leave us without crucial technical support, making the system obsolete.
The requested TIRM microscope will allow us to rapidly achieve our Aims, and we anticipate that
the instrument will be used daily by multiple investigators in the lab over a several year period,
coincident with the funding of the R37.

Public health relevance
Project Narrative Our goal is to obtain a fundamental understanding of how the cytoskeletal motors interact with proteins, lipid membranes, and other biomolecules to power structural arrangements and motile events that are crucial for eukaryotic life. The cytoskeleton and its molecular motors touch nearly all aspects of normal cell function, as these proteins are frequently at the nexus of key signaling and developmental pathways. Additionally, there is a growing appreciation and demonstration that cytoskeletal proteins, molecular motors, and cytoskeletal adaptors are viable therapeutic targets. Thus, a molecular understanding of cytoskeletal function is of direct health relevance.